VEGFR1 and its regulation by thrombin signaling during placental vascular growth

The placenta is a highly vascular organ required to nourish the growing embryo by mediating
exchange of nutrients, gases and hormones with maternal blood. The placenta creates a
complex vascular network in which fetal endothelial cell-lined blood vessels lie in close proximity
to maternal blood. The placenta must grow in concert with the embryo throughout gestation, and
defects in placental growth are a common cause of fetal defects as well as maternal
cardiovascular diseases such as preeclampsia. The origin and growth of the fetal placental
vasculature in the human and mouse placenta are highly conserved, but remain poorly
understood at the molecular and genetic levels. Vascular endothelial growth factor (VEGF) and
its receptors play essential roles in embryonic development, and VEGFR1 (aka FLT1) is tightly
associated with placental dysfunction but distinguish roles of these central vascular regulators in
the embryo and placenta has not been possible. To address this gap in knowledge we have
used new genetic tools, including Hoxa13-Cre knockin mice that drive gene deletion in
endothelial cells of the placenta but not the embryo or yolk sac, and mutant VEGFR1 knockin
alleles, to investigate mechanisms of placental vascular growth. Our preliminary studies reveal a
central role for VEGFR1 during placental vascular growth, and unexpectedly provide evidence
that VEGFR1 may function as an agonist or antagonist during that process. We further find that
the signaling by the coagulation protease thrombin regulates placental endothelial VEGFR1
expression, and is required specifically for placental vascular growth. We propose that VEGFR1
and coagulation activity function as key regulators of placental growth that are tightly tied to fetal
and maternal complications during pregnancy. We will test this central hypothesis by defining
the agonist and antagonist function of VEGFR1 during allantoic vasculogenesis and placental
angiogenesis (Aim 1), and by elucidating the organ-specific role of coagulation factor activity
and its regulation of VEGFR1 function in the placenta (Aim 2). These studies are expected to
yield new insights into the molecular mechanisms of placental vascular growth, the unique role
of VEGFR1 receptors in the placenta, and the critical connection between blood clotting and
vascular growth in the placenta that is required for successful pregnancy.

Public health relevance
The placenta is a vascular organ essential for the growth and health of both the unborn baby and mother, but little is known about its vessel growth. The VEGFR1 receptor and clotting enzymes such as thrombin play unique roles in directing placental vascular growth. Using newly developed mouse genetic tools and human placental tissues, this proposal will define those roles, establishing a new foundation to treat placental vascular diseases.